Molecular Chaperones and Small Molecules

Summary
The long-term goal of this project is to understand the molecular mechanisms of chaperone-mediated, protein
quality control (PQC). Heat shock protein 70 (Hsp70) is known to bind client proteins and make the “decision” to
either fold or degrade them. How does Hsp70 make this choice? Why does it sometimes make the “wrong”
decision? Severe neurodegenerative disorders, including spinobulbar muscular atrophy (SBMA) and
frontotemporal dementia (FTD), are associated with a failure of the Hsp70 system to adequately clear damaged
clients, such as polyglutamine-expanded androgen receptor (polyQ-AR) and microtubule-associated protein tau
(MAPT/tau). We envision that mechanistic knowledge of Hsp70-mediated PQC will uncover new drug targets
that might be used to restore normal protein homeostasis and, ultimately, treat these diseases. Indeed, in the
previous funding cycles, we made substantial progress towards this goal. Specifically, we found that prolonged
binding of Hsp70 to polyQ-AR or MAPT/tau creates a “signal” that recruits the E3 ubiquitin ligase, CHIP, and
triggers a degradation cascade. These new insight were revealed using our chemical probes that selectively
control protein-protein interactions (PPIs). Namely, we have developed molecules that inhibit PPIs between
Hsp70 and its major co-chaperones, the J-domain proteins (JDPs) and nucleotide exchange factors (NEFs). In
the course of this R01 (2008-present), we have shipped these reagents to 100+ laboratories worldwide, enabling
important discoveries about the role of Hsp70 sub-networks in many biological models. Now, in this competitive
renewal, we are excited to propose the next generation of important mechanistic questions and PPI targets. In
preliminary studies, we identified which peptide sequences in polyQ-AR and MAPT/tau bind to Hsp70 and the
JDP, DnaJA2, a potent suppressor of aggregation Taking advantages of these insights and leveraging new
technical innovations, we propose to create “molecular glues” that promote selective and potent binding of polyQ-
AR and MAPT/tau to (SA1) Hsp70 and (SA2) DnaJA2. We also propose to (SA3) create “molecular glues” that
promote binding of Hsp70s and JDPs to each other. As envisioned, these drug-like compounds will stabilize PPI
contacts in the Hsp70 sub-network, promoting selective recognition of polyQ-AR and MAPT/tau and enhancing
their degradation. Thus, we anticipate that these new chemical probes could be the starting point for exciting,
new therapeutics. There is considerable enthusiasm for “molecular glues” in oncology and we are enthusiastic
about taking the lessons (and technologies) from that emerging field and applying them in new ways to probe
Hsp70 sub-networks in models of neurodegeneration. More fundamentally, we expect that these studies will
reveal the molecular logic by which Hsp70 systems conduct PQC and maintain protein homeostasis.

Public health relevance
PROJECT NARRATIVE Neurodegenerative diseases, such as spinal bulbar muscular atrophy (SBMA) and frontotemporal dementia (FTD), are a major burden on patients and their caregivers. These diseases are progressive and lethal, and no treatments exist. This work is significant because we will study how cells normally process the proteins that aberrantly accumulate in SBMA and FTD, potentially revealing new drug targets.